Summer Program of Research Opportunities for Undergraduate Training (SPROUT): Human Development and Disabilities

The Summer Program of Research Opportunities for Undergraduate Training (SPROUT) is
designed as a gateway to scientific research in biomedical and behavioral sciences for
undergraduate students at Cal State LA university. The program will be housed in the
Rongxiang Xu College of Health and Human Services at Cal State LA where nearly 75% of the
students are underrepresented minorities and 73% are first generation college students. Despite
a high interest level in research, most students have had little exposure to research within their
home environments. The majority are working to contribute to their college education making
scholastic experiences beyond credited coursework challenging. The overarching aim of this
program is provide promising students with an opportunity to submerge themselves into an
intensive training environment for 15-weeks where we can accomplish the following three aims:
(a) to develop students' research skills in behavioral and biomedical sciences as well as in the
content areas of rehabilitation and child development research (b); to prepare students for
advancement in behavioral and biomedical sciences in graduate school and (c) to introduce the
students to research careers in biomedical and behavioral sciences. Students will have two
research rotations allowing them the opportunity to gain expertise in both behavioral and
biomedical sciences and with the addition of workshops and other activities, students will be
trained in scientific writing; analytical techniques; data management and data presentation. A
strength of the proposal is that the diverse SPROUT faculty understand the unique needs of the
Rongxiang Xu College students. Thus, the Program is designed to instill self-confidence, and
self-worth and to develop self-efficacy and communication skills. Together the experiences will
fill the scientific “tool box” of the SPROUT Scholar to help them develop a scientific identity they
need to be successful in the fields of biomedical and behavioral sciences.

Public health relevance
The Summer Program of Research Opportunities for Undergraduate Training (SPROUT) is a summer research training program for undergraduates in the Rongxiang Xu College of Health and Human Services (HHS) at Cal State LA University. The program is designed to train underrepresented students in the biomedical and behavioral sciences. The program has garnered the strength of the diverse research faculty within the College to focus this training specifically in the fields of rehabilitation and human development.